Advancing the Quality of Cancer Care through Behavioral Economics and Implementation Science

The grand challenge addressed by the Penn Implementation Science Center in Cancer Control (Penn ISC3) is
to apply insights from behavioral economics to accelerate the pace at which evidence-based practices for cancer
care are deployed to improve outcomes for individuals with cancer. Penn offers a unique environment in which
to conduct this paradigm-shifting work, given our expertise in implementation science, behavioral economics,
and innovative cancer care delivery. The complementary and multi-disciplinary expertise of the three MPIs (Bei-
das, Bekelman, Schnoll), coupled with existing Penn resources, including the Penn Center for Cancer Care
Innovation [PC3I], the Center for Health Incentives and Behavioral Economics [CHIBE], and the Penn Imple-
mentation Science Center at the Leonard Davis Institute [PISCE@LDI], represent a unique opportunity to ad-
vance the quality of cancer care. The Administrative Core, led by Drs. Beidas, Bekelman, and Schnoll, will ensure
that the activities of Penn ISC3 are coordinated, synergistic, and congruent with timelines. The Implementation
Laboratory, led by Drs. Bekelman and Shulman, represents a diverse ecosystem that includes five hospitals and
linked clinical sites, with over 200 oncologists that serve over 15,000 unique new patients annually. Our Research
Program, led by Drs. Beidas and Buttenheim, will oversee the development and testing of implementation strat-
egies that target patients and clinicians within our Implementation Lab and are centered on the idea of ‘nudging’
for optimal implementation and effectiveness outcomes. The Research Program includes investigators with ex-
pertise in implementation science, behavioral economics, cancer care delivery research, healthcare innovation,
measurement, and mixed methods. In the first two years, we propose three Signature Pilot Projects and two
Methods Projects with a commitment to rapid learning that will allow Penn ISC3 to be optimally nimble. Signature
Pilot Project 1 (Jenssen/Leone) tests patient- and clinician-directed implementation strategies to increase referral
to tobacco cessation programs among cancer patients. Signature Pilot Project 2 (Bekelman/Patel) tests patient-
and clinician-directed implementation strategies to increase higher-value bone modifying agents in patients with
breast, lung, and prostate cancer. Common methods and measures are linked to allow for pooling of data and
to accomplish our objectives of testing multilevel implementation strategies and mechanisms across contexts.
Our exploratory and high-reward Signature Pilot Project 3 (Bekelman/Rendle) will test a patient-directed imple-
mentation strategy that leverages artificial intelligence and machine learning to promote oral chemotherapy ad-
herence and symptom management. Two methods projects, in support of the Projects, will advance the science
of implementation methods. Methods Project 1 will develop a toolkit for the application of rapid cycle approaches
(Asch/Buttenheim); Methods Project 2 will use qualitative comparative analysis to characterize multilevel con-
textual variation (Barg/Rendle). The Penn ISC3 has the potential to identify novel, disseminable, and scalable
ways to advance the quality of cancer care and improve the health outcomes for individuals with cancer.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
PROJECT NARRATIVE The goal of the proposed Penn Implementation Science Center in Cancer Control (Penn ISC3) is to advance the science and practice of implementing evidence-based practices for individuals with cancer. The creation of the Penn ISC3 will leverage the deep expertise and resources at the University of Pennsylvania in implementation science, behavioral economics, and cancer care delivery research to address strategic priorities emphasized in the National Cancer Institute Moonshot Blue Ribbon Panel. Specifically, our focus and grand challenge theme is to test implementation strategies informed by behavioral economics to improve uptake of evidence-based practices within our Implementation Laboratory, Penn Medicine, including those from traditionally underserved populations, to improve the lives of individuals with cancer. Penn ISC3 will produce new knowledge with the potential to reduce the research-to-practice gap in cancer care and improve outcomes for millions of Americans. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page